Novel Therapy for the Common Cold

in application instructions under "Type Size." Appendix (Three sets. No page numbering necessary for Appendix.) Number o' publications and nanuscripts accepted for publication (Not to exceed ten): ot Other iterrs (list): 1. Ma, J., B. Hiknnat, K. Wycoff, N. Vine, D. Chargelegue, L Yu, M. Hein, and T. Lehner 1998. Characterization of a recombinant plant monoclonal secretory antibody and preventive immunotherapy in humans Nature Medicine. 4:601- 606. 2. Larrick JW, Yu L, Chen J, Jaiswal S, Wycoff K. 1998. Production of antibodies in transgenic plants. Res. Immunol. 149:603-608. PHS 6246-2 (Rev. 1/98) Page 3